CE25-029 - Enhancing an existing prevention strategy to reduce intentional firearm injuries among high-risk youth

PROJECT SUMMARY/ABSTRACT
Substantial resources have been devoted to developing effective youth violence prevention (YVP) programs
over the past 30+ years. However, firearm-specific risk factors were largely overlooked in the development of
these programs due to previous barriers to studying firearm violence. This is concerning as firearms are a leading
cause of injury and mortality among youth. There is a dire need to develop effective prevention strategies for
intentional firearm injuries, particularly strategies that address cross-cutting risk factors for firearm-related
violence and suicide. Rather than re-inventing the wheel, it is logical and feasible to enhance existing YVP
programs to address firearm-specific risk factors for intentional injury. This project will use youth participatory
action research to develop and test the preliminary effectiveness of SAFE Futures, a single-session intervention
that will address cross-cutting risk factors for intentional firearm injuries from violence and suicide. A randomized
controlled trial will be conducted to determine whether adding SAFE Futures to an existing YVP program for
high-risk youth, Emerging Leaders, reduces firearm violence and suicide above and beyond Emerging Leaders
alone. Importantly, this project will also examine the economic efficiency of SAFE Futures. SAFE Futures has
great potential to be a cost-effective, resource-efficient tool to enhance YVP programs’ effectiveness in
preventing intentional firearm injuries among youth. This project is closely aligned with CDC’s research priorities
for interpersonal violence and cross-cutting prevention. The findings will inform an R01 proposal to conduct a
larger RCT of SAFE Futures that builds on the proposed work. Importantly, this award will enable Dr. O’Connor,
a promising early-stage investigator, to acquire skills and knowledge in community-engaged and qualitative
research methods, clinical trials research, economic analysis, and cross-cutting risk factors for firearm injuries.
Virginia Commonwealth University and its Level 1 Trauma Center provide a rich context for Dr. O’Connor’s
career development, which is bolstered by a multidisciplinary team of expert mentors with substantial expertise
relevant to her research and career goals and a successful track record of mentoring junior faculty into
independent investigators. Ultimately, this K01 award will equip Dr. O’Connor with the training and protected
time necessary to initiate a high-impact program of research on strategies to prevent intentional firearm injuries
among youth.

Public health relevance
PROJECT NARRATIVE The proposed project will use youth participatory action research to develop and test SAFE Futures, a novel single-session intervention that can be added to existing prevention strategies to enhance their effectiveness in reducing intentional firearm injuries and fatalities from violence and suicide. Following a youth-driven development phase, the preliminary acceptability, effectiveness, and economic efficiency of SAFE Futures will be assessed through a RCT in which high-risk youth are randomized to receive either Emerging Leaders, an existing selective prevention strategy that does not address firearm-specific risk factors, or Emerging Leaders+SAFE Futures. Importantly, the K01 Award will provide Dr. O’Connor with the expert mentorship, training, and protected time necessary to initiate a high-impact program of research on cross-cutting prevention strategies for intentional firearm injuries among youth.